Disrupted Sleep in Somali Americans – Implications for Hypertension Risk

Disrupted sleep, a major public health issue, independently increases risk for cardiovascular disease
(CVD). Blacks have increased rates of sleep deficiency, which are likely under-reported. Importantly, these
data relate primarily to those of West African ancestry. Our current knowledge of sleep disruption in Blacks,
already severely limited in scope, cannot be readily applied to Somali Americans. The majority of Somali
immigrants have settled in Minnesota, placing our Minnesota-based research team in a unique position to
comprehensively study the mechanisms and consequences of disrupted sleep as a mediator of cardiovascular
health disparities in this population. Our preliminary data suggest that Somali Americans have a high likelihood
of disrupted sleep, which may put them at increased risk for hypertension and other CVD. Underlying
sociocultural, behavioral, environmental and biological factors likely contribute to an increased risk for sleep
deficiencies. We therefore propose an inter-disciplinary approach using a socioecological model
informed by the National Institute on Minority Health and Health Disparities (NIMHD) Research
Framework to determine the types and severity of undiagnosed sleep deficiencies in otherwise healthy
Somali Americans, identify mechanisms contributing to their disrupted sleep, and examine the role of
sleep deficiencies in raising blood pressure (BP). Our central hypothesis is that Somali Americans will
have a high likelihood of sleep deficiencies attributable in part to unique multilevel individual, psychosocial,
contextual and behavioral factors, which exert deleterious biological effects. We propose the following aims:
Aim 1: Determine the types and severity of previously undiagnosed sleep deficiencies in otherwise
healthy Somali Americans. Hypothesis 1: Somali Americans have a high (>50%) likelihood of previously
undiagnosed sleep deficiencies (short sleep (<6 hours), insomnia and obstructive sleep apnea).
Aim 2: Apply the NIMHD Research Framework to define psychosocial, behavioral, environmental and
biological mechanisms mediating sleep deficiencies in Somali Americans. Hypothesis 2: Unique
multilevel individual, cultural and environmental risk and protective factors play a mechanistic role in
mediating an increased likelihood of disrupted sleep in Somali Americans.
Aim 3: Examine the relationship between sleep deficiencies and increased BP in Somali Americans.
Hypothesis 3: BP during wakefulness and/or sleep will be increased in those subjects with disrupted sleep,
commensurate with type and severity of sleep deficiency, and moderated by factors such as sex and age.
The expected outcome of this proposal will be a mechanistic pathway incorporating the NIMHD Research
Framework to identify psychosocial, behavioral, contextual and biological factors mediating sleep deficiencies
and related increases in BP, and consequently hypertension risk, thus addressing important knowledge
gaps in understanding sleep-related health disparities and their consequences in Somali Americans.

Public health relevance
Project Narrative: The Somali American immigrant community has high risk for obesity, hypertension, metabolic syndrome and diabetes, all of which are frequent comorbidities of deficient sleep, including short sleep duration, obstructive sleep apnea, and insomnia. We plan to examine the likelihood, types and severity of disrupted sleep in Somali Americans, identify mechanisms that may be causing the sleep deficiency, and explore how the sleep problem may be leading to increases in daytime and night time blood pressure. These findings will address important knowledge gaps in understanding health and disease in Somali immigrants, and provide actionable insights to help in preventing any future epidemic of cardiovascular and metabolic disease in this relatively young population.